Center for Cancer Research Genetics Core

The genetics core is focused on human disease population cohort studies and is organized into two functional units: biospecimen curation and genotyping/sequencing. Disease cohorts include numerous HIV-infected cohorts, nasopharengeal carcinoma, and hepC, among others. Biospecimen curation unit recieves samples, makes cell lines and DNAs. Cell lines serve as a renewable source of DNA. DNAs are aliquoted onto multiwell plates for sequencing or genotyping by that unit of the core, or for sending to collaborators.